RCMI@Morgan: Center for Urban Health Disparities Research and Innovation

PROJECT SUMMARY– Overall
During the current grant cycle, RCMI@Morgan has significantly contributed to advancing the science of health
disparities. In the next 5 years, our overarching goal is to develop a more robust biomedical research ecosystem
to foster innovative biomedical, socio-behavioral and clinical research aimed at improving minority health and
reducing or eliminating health disparities in urban communities. This goal will be achieved through five specific
aims: 1) Strengthen the capacity of MSU to conduct innovative biomedical, socio-behavioral and clinical
research addressing health disparities issues of concern to urban communities; by: (i) developing and
implementing mechanisms and processes to enhance health disparities research; (ii) hiring a senior biomedical
scientist to strengthen the biomedical research ecosystem; (iii) supporting three innovative research projects
designed to address health disparity diseases that disproportionally affect minorities and underserved
communities; and (iv) enhancing the program website to foster effective communication. 2) Strengthen the
biomedical research ecosystem to further support innovative research on health disparities issues of
concern to urban communities; by: (1) creating a robust research ecosystem that fosters multidisciplinary
collaborations and biomedical research convergence of many disciplines; (ii) strengthening the Research
Capacity Core and improving its management to foster sustainability. 3) Create opportunities for professional
development and career enhancement of early stage investigators; by: (i) leveraging the Investigator
Development Core (IDC) to create a robust pilot project program that helps ESIs conduct innovative, hypothesis-
driven research and gather the preliminary data needed to develop and submit stronger proposals (R-type) for
competitive grants from NIH or other agencies; (ii) Implementing specific career development activities to
facilitate the transition of ESIs to biomedical research independence. 4) Foster opportunities for translational
research; by: (i) leveraging the Community Engagement Core to build sustainable relationships with community-
based organizations; (ii) promoting community-academic partnerships to address urban health disparities issues;
(III) fostering community participation in biomedical research, and full engagement in research development and
implementation; and (iv) disseminating research findings to improve minority health; and (v) fostering strong
partnerships to enhance the biomedical research environment and maximize productivity. 5) Perform a
comprehensive evaluation of all the strategic activities of the Center; by: (i) Collecting and analyzing data
on all programmatic activities of the Center based on the logic model that has been developed to guide the
Center evaluation; (ii) conducting both formative and summative evaluations of major components of the Center;
(iii) documenting successes and identifying areas of improvement; and assessing the overall impacts of the
Center on the science of health disparities and the development of biomedical workforce.

Public health relevance
PROJECT NARRATIVE – Overall During the current grant cycle, research conducted by RCMI@Morgan has significantly contributed to improving the health of minority and underrepresented communities in Baltimore and Maryland. Over the next 5 years, the Center will develop a more robust biomedical research ecosystem to foster innovative biomedical, socio- behavioral and clinical research aimed at improving minority health and reducing health disparities. The Center will empower MSU investigators to conduct innovative research on the underlying mechanisms that lead to health disparities, and to translate new knowledge into interventions to reduce or eliminate adverse health outcomes.